Split-GFP tagging and live imaging of hair cell proteins

Over the past few decades, the hair cell field has gained great insight into the inner workings of hair cells, the
sensory receptors that mediate our sense of hearing and balance. The molecular identity of many factors
important for hair cell development and function, and their significance for hearing loss, have been elucidated.
Despite this progress, the study of hair cells presents many challenges. In particular live-cell imaging and
tracking of proteins, important pillars of cell biology studies, have been especially difficult, mainly due to limited
means to transfect and culture hair cells. Considering that the essence of hair cell function is micro- and
nanoscale movement, investigations of the dynamic properties of proteins is crucial for a complete
understanding of hair cell function. The goal of this proposal therefore is to develop a tool that makes imaging
of protein movements in living hair cells more accessible.
The gold standard technique for tracking protein movement is live-cell imaging of tagged proteins. Traditionally,
this is achieved by expression of exogenous DNA constructs fused to fluorescent proteins, delivered to cells by
gene gun, electroporation or viruses. Transgenic mice also have been employed. These approaches, however,
are potentially confounded by overexpression artifacts and low transduction/transfection efficiency. Knock-in
(KI) of genetically-encoded fluorescent tags into the endogenous gene loci has become more tractable through
modern genome editing methods, but KI of large DNA segments, such as the full-length GFP coding sequence,
remains difficult and has the potential to affect gene expression.
To address these challenges, we plan to develop a mouse tool kit that streamlines fluorescent tagging of
proteins for localization and live cell imaging. To this end, we adopted the Split-GFP strategy. In this two-
component system, the endogenous gene of interest is genetically tagged with a small part of GFP (“GFP11”).
Co-expressing the remaining (non-fluorescent) portion of GFP (“GFP1-10”) reconstitutes GFP fluorescence,
allowing imaging by fluorescence microscopy. Due to the small size of the GFP11 fragment (48 bps), CRISPR-
mediated KI into the endogenous loci is highly efficient. In preliminary studies, we confirmed that the Split-GFP
approach faithfully recapitulates the endogenous localization of the cuticular plate protein LMO7, by delivering
AAV-packaged GFP1-10 into the hair cells of Lmo7-GFP11 KI mice. To circumvent AAV-mediated delivery, we
propose to generate a transgenic mouse line that expresses the GFP1-10 fragment. Founders have already
been obtained and germline transmission was confirmed (SA1). This system will be tested on live-imaging
tasks of increasing difficulty: In SA2, we will study the diffusion kinetics and movement of LMO7 in the hair cell.
In SA3, challenging the sensitivity limits of this system, we will investigate the dynamics of the tip link motor
complex component USH1C in the hair bundle.

Public health relevance
Hair cells in the inner ear mediate our sense of hearing and balance. The molecular identities of many components important for hair cell development and function, and their significance for hearing loss, have been elucidated. To understand the role of these proteins in various hair cell functions, investigations of their dynamic behavior are essential. To this end, we plan to adopt the Split-GFP approach to develop a mouse tool kit that makes fluorescent tagging and imaging-assisted tracking of proteins in living hair cells more accessible.